Core A - Administrative Core

Core A will continue to provide scientific, fiscal, administrative, and logistic oversight to all aspects of the Center. As before. Core personnel will facilitate communication among investigators and the sharing of reagents, tools, specimens, and data to ensure appropriate allocation and effective use of Center funds. The Core will also continue to: provide clerical support; coordinate interactions between facility cores and research projects; organize regular investigator meetings and; provide biostatistical support. In addition to these functions, the Core will develop and implement a clear path for transition to and attainment of independent status and for the continued career development of early career investigators . The Core will provide leadership and administrative support needed to maintain the thematic focus of the Center and to achieve Center goal. It will provide mentorshp to early-career investigaotrs by expanding curernt mentoring activitis, while continued to provide personalized mentoring. Core personnel will encourage the exploratoin of new research avenues and phase out unpromising resarch and maximize the intellectual environment of the Center. The Core will also provide statistical support to assist in study design and analysis and help in developing grant proposals. It will monitor evaluate overall Center progress in achieving specific milestones. Core personel will prepare annual scientific reports and financial statements and plan and organize symposia, seminars and regulary-scheduled meetings. They will invite prominent scientists to present seminars and interact with Center members and communiate with University and NIH officials to report progress and discuss Center related issues. In consultation with the external and internal advisory committee, the Program Director will recruit new faculty to replace graduating COBRE investigators and if required increase the critical mass of investiagtors working in the Center. If required, Core A will adopt remedial measures for Principal Investigators who fail to satisfactory review by the External Advisory Committee. The Core will also maintain a Center Website and faciliate the dissemination of information about Center activities as well as diabetes and obesity.

Public health relevance
The Core will provide administrative support to the Diabetes and Obesity Center at the University of Louisville and therefore contribute to the development of new and effective strategies for prevention and treatment of diabetes and obesity research by facilitating research in this area and by providing mentoring and training to the next generation of scientists.